The pivotal role of macrophages in regulating pulmonary fibrosis

PROJECT SUMMARY/ABSTRACT
Idiopathic Pulmonary Fibrosis (IPF) is a progressive and fatal disorder of excessive collagen deposition by
fibroblasts resulting in reduced lung elasticity and poor survival. Despite ongoing efforts and new
pharmacologic agents, only limited efficacy has been achieved to delay disease progression. This likely
reflects the complex nature of the disease including vital cell-cell interactions. Recently, we identified critical
interactions between macrophages and fibroblasts which led to the development of pulmonary fibrosis. Our
data demonstrate that interleukin-1 receptor associated kinase (IRAK)-M, a negative regulator of Toll-like
receptor signaling, was elevated in macrophages from human IPF patients and murine macrophages after
bleomycin-induced pulmonary fibrosis and lead to enhanced collagen expression by fibroblasts. Using our
experimental murine model of fibrosis, we demonstrate that mice deficient in IRAK-M are protected from
pulmonary fibrosis and this effect is dependent on IRAK-M expression in macrophages. The goal of this
proposal is to investigate the mechanism by which macrophage expression of IRAK-M regulates the
development of pulmonary fibrosis. In order to accomplish this, we propose two specific aims. In specific aim 1,
we will investigate the role of IRAK-M in regulating monocyte trafficking to the lung during pulmonary fibrosis.
Lung macrophage are either derived embryonically from the yolk-sac or are bone marrow-derived from
circulating monocytes. We will interrogate the role of IRAK-M in regulating monocyte trafficking using adoptive
transfer, competitive bone marrow transplantation model, and cell-specific IRAK-M knockout mice. In addition,
we will investigate the role of IRAK-M in regulating expression of profibrotic genes and CCR2, the chemokine
receptor involved in monocyte recruitment, using macrophages isolated from bleomycin challenged mice as
well as primary macrophages from IPF patients and normal, donor controls. To show translational relevance,
we will use our characterized human samples to generate a humanized IPF mouse model with cells from IPF
patients. In specific aim 2, we will determine the role of IRAK-M in regulating macrophage function, specifically
their ability to identify, take up and degrade collagen in the lung during pulmonary fibrosis. We will assess the
role of IRAK-M in the uptake of collagen fragments after bleomycin challenge. Macrophage and monocyte
populations from our murine models as well as cells isolated from IPF patients and normal donor controls will
be flow sorted and we will measure the expression of IRAK-M, collagen uptake receptors, and collagen
degradation enzyme expression and activity. Finally, we will establish a macrophage-fibroblast co-culture
system to investigate the bidirectional interactions that these two cell types exert on each other. These studies
will provide the foundation for the development of novel biomarkers of disease as well as new interventions
based on specific molecular targets that should improve the human health of IPF patients.

Public health relevance
PROJECT NARRATIVE IPF affects roughly 128,000 people a year in the United States with a medium life expectancy of only 3 years after initial diagnosis; although novel therapeutic options are emerging and being tested in patients diagnosed with IPF, many patients still require orthotropic lung transplantation as a rescue treatment strategy. To develop molecular targets for the diagnosis and treatment of IPF, additional insight into the mechanism of disease is required. We propose to examine the role for a previously under-appreciated cell type, the macrophage, in pulmonary fibrosis in order to identify biomarkers of disease and novel targets for therapeutics.